Training in Infectious Diseases in Peru - Time for Implementation Research

Implementation Research in Infectious Diseases in Peru – GARCIA, Hector H.
Training in Infectious Diseases in Peru –
Time for Implementation Research
PROJECT SUMMARY
This renewal application proposes to apply the training experience built in Peru over the past 25
years with Fogarty support, and take advantage of the now existing cadre of well-trained clinical
researchers, to guide a new generation of trainees into objective-driven implementation research (IR).
In this five-year period, our trainees will be oriented to produce research aimed to improve policies
and practices in our region. The basic foundations of our program (continuous hands-on participation
in these studies and a step wise system involving a Diploma course in Research Methods, a Master’s
degree in Epidemiology or related fields, advanced courses overseas, and PhD studies), combined
with a wide array of ongoing research programs by our mentors, provide an optimal framework for
this objective. We have succeeded in forming independent researchers, many of whom now head
their own research labs and have obtained competitive grant funding.
Specifically, we will enroll 50 medium-term mentored post- and pre-graduate students in a
Diploma course (10 per year), 22 mentored Master’s degree students (5 in years 1 to 3, 2 each in
years 4 and 5), and up to four PhD students including two enrolled in the UPCH PhD program. With
the addition of the experienced IR team of the U. of Washington, courses in the foundations and
practice of implementation research will be incorporated into the curricula of the Diploma, master’s
and PhD programs. We will include online versions of these Diplomas and Master´s courses to allow
trainees from less favored regions to enter our research training pathway, and to address changing
norms post SAR-CoV-2.
We will also establish an implementation unit within the university´s Center for Clinical Studies,
providing trainees with exposure to ongoing clinical studies and allowing the inclusion of IR expertise
at the planning stage of clinical trials, rather than at the end when required information is found not to
have been recorded and translation efforts are many times lost. By the end of every year, our trainees
will submit research proposals with a focus on implementation that will be evaluated by an external
expert panel. The top two will be funded each year. Successful applicants will attend the annual 2-
week Implementation Science Institute at UW. They will also be supported by a mentor with
experience in IR, a thematic mentor, and a prior trainee with more research experience, providing
necessary guidance to perform their proposed study over one year.
Another addition will be a mentor development track aimed to incorporate up to 24 young mentors,
mostly prior trainees. They will receive training and the appropriate tools to develop their mentoring
skills through interaction with senior mentors, yearly mentorship workshops, online courses, etc., and
will be evaluated in terms of specific deliverables such as thesis advice, research supervision,
publications, and grant submissions from their assigned trainees.
Focusing on implementation research to improve activities or processes in the health system
should capitalize in this critical mass and provide trainees and mentors a new, productive perspective
while at the same time contribute to a much-needed reduction of inequalities in health.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
Implementation Research in Infectious Diseases in Peru – GARCIA, Hector H. Training in Infectious Diseases in Peru – Time for Implementation Research NARRATIVE This renewal application builds on a long-term Fogarty-supported training program that has trained hundreds of young Peruvian scientists in infectious disease research. While the program maintains its basic foundations including continuous hands-on participation in ongoing research studies and a step wise system involving a Diploma course in Research Methods, a Master’s degree in Epidemiology or related fields, advanced courses overseas, and PhD studies, over the next five-year period we will focus on guiding a new generation of trainees into objective-driven implementation research aimed to improve policies and practices in our region. We have succeeded in forming independent researchers through this training program, many of whom now head their own research labs and have obtained competitive grant funding. Focusing on implementation science should guide new trainees to help translate the research capacity built over the years into pragmatic, evidence-based solutions to public health problems in the region and elsewhere. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page